Combinatorial Neuroprotective Strategies for Preterm Brain Injury

PROJECT SUMMARY
Preterm birth remains a major cause of mortality and morbidity globally and in the United States. Fortunately,
over the past several decades, mortality has decreased such that survival is now over 90% in high income
countries. Unfortunately, commensurate improvements in neurodevelopmental outcomes of extremely preterm
infants (EP, born <28 weeks’ gestation) remain elusive, with more than 60% of survivors developing at least one
disability such as cerebral palsy, autism, ADHD, or cognitive, hearing, or visual impairment. There are no
targeted neuroprotective interventions for preterm infants in current clinical use, driving a significant clinical need
to develop therapies that reduce the mortality and long-term morbidity seen in EP infants. To evaluate promising
therapeutics in the preterm infant, we have developed complementary in vitro and in vivo techniques in the
developing ferret. Our preliminary data in the inflammation sensitized hypoxic-ischemic-hyperoxic (HIH) ferret
model of preterm brain injury shows injury patterns and behavioral changes consistent with those seen in infants
born prematurely. In cultured organotypic ferret brain slices exposed to oxygen-glucose deprivation (OGD), we
have also shown regionally dependent injury, similar to the preterm human, and regional and treatment-
dependent transcriptome changes associated with neuroprotection. The fact that we see regionally dependent
responses to therapy suggests that an optimal therapeutic approach will require combinatorial therapies to
provide global neuroprotection and improve long-term neurodevelopmental outcomes. This is particularly
relevant considering the recent publication of the PENUT trial, which found no significant neuroprotective effect
of erythropoietin (Epo) monotherapy – one of the most promising therapies in the pipeline – in EP infants.
Organotypic brain slices can provide a platform to screen combinatorial therapeutics including their interactions.
For example, our preliminary data in EP-equivalent ferret brain slices shows Epo in combination with the anti-
inflammatory antibiotic azithromycin results in synergistic benefit in the subcortical white matter, a region that is
specifically at risk in EP infants, but this combination does not result in benefit in all brain regions. Building on
these findings, the objectives of our proposed research are to (1) determine the regional specificity and efficacy
of multiple promising neurotherapeutics in vitro, (2) evaluate combined neurotherapeutics to optimize regional
and global neuroprotection in vitro, and (3) develop a cocktail of neurotherapeutics optimizing neuroprotection
in vivo in a ferret model of EP brain injury. Our overarching hypotheses are that: (1) neurotherapeutics that
provide complementary region-specific neuroprotection in vitro will increase global neuroprotection in vivo, and
(2) that compared to monotherapy, combining complementary neurotherapeutics will result in greater
neuroprotection across the entire brain that persists into adolescence. Data resulting from this proposal could
support a clinical trial in this population for which no specific neuroprotective therapies are currently available.

Public health relevance
PROJECT NARRATIVE Nearly 10% of infants are born prematurely, with outcomes including behavioral and cognitive problems, severe disability, and death. There are currently no targeted neuroprotective interventions for preterm infants, and mounting evidence suggests that multiple therapies will need to be applied in order to see robust global neuroprotection. In this proposal we describe complementary in vitro and in vivo techniques in the early preterm ferret to determine combinatorial therapies with the greatest likelihood of benefit – we provide a preclinical platform that can create a pipeline for translation to clinical neuroprotection trials in premature infants.